GLUTAMINE SUPPLEMENTATION OF PERIPHERAL INTRAVENOUS FLUID

This project is designed to study the effect of peripheral intravenous fluid on nitrogen balance, body composition, fatigue and immune function in healthy volunteers who fast for five days.